A mouse model of HUWE1 syndrome

Abstract
Protein ubiquitination is crucial for cellular homeostasis, impacting protein quality control and the regulation of
signaling molecules. HUWE1, a ubiquitin E3 ligase, ubiquitinates a variety of substrates, including p53 and MYC,
and its role in development and disease is not fully understood. Mutations in HUWE1 have been linked to rare
mental disorders and intellectual disabilities. Notably, many of these mutations occur in the catalytic HECT
domain, suggesting altered HUWE1 activity. However, the relationship between these mutations and
neurological conditions remains unclear, partly due to the absence of an appropriate animal model. To address
this, we generated a Huwe1R4190C knock-in mouse model carrying a mutation corresponding to a frequently
reported mutation in human HUWE1. Preliminary observations indicate that these mice exhibit decreased social
exploration and object recognition. Our overarching objective is to characterize the neural development of these
mice to understand how HUWE1 mutations contribute to mental and intellectual disorders. Our central
hypothesis posits that the Huwe1R4190C mutation disrupts normal HUWE1 function, leading to abnormal protein
degradation and subsequent dysregulation of neuronal proliferation, differentiation, and synaptic function. We
will test this through two specific aims: (1) to determine the impact of the Huwe1R4190C mutation on neural
progenitor proliferation and neuronal differentiation in the developing brain, and (2) to investigate whether the
Huwe1R4190C mutation affects excitatory and inhibitory synapse formation in the postnatal brain. This pilot study
will elucidate the role of the Huwe1R4190C mutation in neural development and provide a valuable model for future
HUWE1 research, laying the groundwork for subsequent studies on the molecular mechanisms underlying
HUWE1-related neurodevelopmental disorders. Additionally, the insights gained from this study could inform
potential therapeutic strategies targeting HUWE1-associated pathologies. The successful completion of these
aims will also position us to pursue a competitive multi-PI R01 application, fostering collaborative research efforts
within the Brain Health Research Institute (BHRI) at Kent State University. By establishing a comprehensive
understanding of HUWE1’s role in brain development, we aim to make significant contributions to the field of
neurogenetics.

Public health relevance
Project Narrative HUWE1 is a ubiquitin E3 ligase that promotes the degradation of substrate proteins. Recently, several studies have reported HUWE1 gene mutations in patients with intellectual disabilities and mental disorders. This one- year pilot study will investigate how a clinically relevant mutation in the HUWE1 gene affects brain development and functions using a novel mouse model. 1